Excitotoxicity and Mitochondrial Dysfunction in Circulatory Arrest- Brain Injury

Project Summary / Abstract
This application builds on our laboratory's pioneering work delineating critical neurochemical mechanisms of
excitotoxicity and neuroinflammation in a translational model of brain injury from hypothermic circulatory arrest
(HCA) that is directly relevant to the techniques currently used in patients undergoing complex heart and aortic
surgery. We propose to test these mechanisms, specifically N-methyl-D-aspartate (NMDA) antagonism with
ketamine and mitochondrial adenosine triphosphate potassium (KATP) activation with diazoxide, using targeted
delivery with dendrimer conjugation in our translational HCA model with the addition of antegrade cerebral
perfusion. Prolongation of the safe HCA time during complex aortic surgery with such agents will dramatically
reduce neurological injury and improve outcomes in these patients.
By identifying the underlying mechanisms of injury and testing them in a pre-clinical large animal model, the
work proposed in this application will advance the field because there are no currently available pharmacologic
agents that have been proven in randomized trials to provide significant improvement to the current use of
hypothermia. We propose the following aims: 1) To determine if the NMDA receptor antagonist ketamine is a
neuroprotectant during hypothermic circulatory arrest in a canine model, 2) To determine the mechanisms of
mitochondrial injury during hypothermic circulatory arrest and the effectiveness of mitochondrial KATP channel
openers as neuroprotective agents in a canine model, and 3) To evaluate targeted neuroprotective strategies in
a hypothermic circulatory arrest model with antegrade cerebral perfusion (ACP)
Our multidisciplinary team includes a practicing cardiac surgeon who experiences the current challenges
when performing complex aortic surgery, a practicing neurologist specializing in brain injury and mitochondrial
stress, a practicing neurosurgeon who specializes in brain injury, a neuroscientist with expertise in brain injury
and mechanisms of neurorepair and microglial activation, the co-director of the Center for Nanomedicine with
expertise in dendrimer-drug nanodevices for targeted therapy to attenuate neuroinflammation, and a
neuropathologist that specializes in neural cell death and mitochondrial pathobiology. Together we possess the
unique ability to translate our findings to clinical practice.
The proposed experiments provide a comprehensive approach to understanding the mechanisms of
neurological injury due to hypothermic circulatory arrest. The knowledge gained could potentially provide benefit
for any patient with cardiovascular disease who requires cardiac surgery, which remains the #1 killer of men and
women in the United States.

Public health relevance
Project Narrative This proposal will investigate injury to the brain during heart surgery using subcellular, cellular, and large animal models. Our laboratory has extensive experience with these mechanisms and models and has demonstrated some of the mechanistic pathways that underlie this brain injury. Additional pathways of injury remain unknown. By improving the knowledge of these mechanisms of injury and testing them in models that can be translated to human trials, this proposal has the potential to help hundreds of thousands of patients who suffer from cardiovascular disease.